Characterization of Plasmodium falciparum long non-coding RNAs and their roles in gene regulation

Abstract
Malaria remains a major public health problem worldwide and, partially due to our incomplete understanding of
the biology of Plasmodium falciparum, our progress towards eradicating the disease has stalled in recent years.
Long non-coding RNAs (lncRNAs) have emerged as a key component of gene regulation in eukaryotes,
influencing both the transcription of genes and the stability and translation of mRNAs. While specific lncRNAs
have been shown to regulate pathogenesis and parasite development, we still lack a comprehensive perspective
on the importance of lncRNAs in P. falciparum. Here, we propose to use a combination of state-of-the-art
genomic and molecular approaches to examine the role of lncRNAs in gene regulation and their modes of action.
First, we propose to evaluate, at the genome scale, how lncRNAs influence the regulation of gene expression of
neighboring and distant genes using a suite of computational approaches and novel genomic assays. Second,
we will comprehensively examine the role of a new antisense lncRNA located downstream of ap2-g, the gene
that encodes a transcription factor that acts as the master regulator of sexual commitment in malaria parasites.
To do this, we will generate genetically modified parasite lines which modulate the levels of the ap2-g lncRNA
using a variety of molecular approaches and we will phenotypically characterize the resulting effects on both
asexual and sexual blood stage malaria parasite development. Overall, the proposed analyses will provide novel
insights into the roles of lncRNAs in gene regulation in Plasmodium parasites. The results of this proposal will
lay the foundation for future studies aimed at characterizing additional well-curated, and developmentally
regulated P. falciparum lncRNAs.

Public health relevance
Project Narrative Malaria causes half a million deaths every year and progress in disease control and elimination has recently slowed, partially due to our incomplete understanding of the biology of its main causative agent, P. falciparum. Using a unique combination of genomic and bioinformatic approaches and state-of-the-art molecular parasitology assays, we propose to rigorously and comprehensively examine the role of long non-coding RNAs (lncRNAs) in regulating P. falciparum gene expression and parasite development.